STUDY OF COMBINED ZIDOVUDINE-LAMIVUDINE VS DDI MONOTHERAPY VS ZIDOVUDINE

The purpose of this study is to determine which combination of antiretroviral therapy is effective is lowering the progression of HIV disease in children and preventing HIV antiretorviral drug resistance.